Host genetic variation affecting the microbiome in rhesus macaques

PROJECT SUMMARY
An increasing body of literature has focused on associating the microbiome with human diseases including
obesity, type II diabetes, cardiovascular disease, cancers, and psychiatric disorders such as autism,
schizophrenia, and depression. While these associations are still relatively nascent and largely correlative, it
has not stopped the push towards development of therapeutics aimed at manipulating the microbiome in an
effort to treat these disorders. There remain, however, a great deal of unknowns surrounding the microbiome
ranging from the factors responsible for its composition to the nature and sources of inter-individual variability
to the actual causative links between microbiome and disease, particularly in humans. This is complicated by
differences in physiology and microbiome composition between humans and rodent models and the pervasive
effects of the environment that cannot be controlled for in humans. This proposal uses 1300 rhesus macaques
from 4 colonies to investigate variability in the gastrointestinal, oral, and nasal microbiome. It will characterize
the inter-individual variability that exists across animals and further develop the rhesus macaque as a model
for human microbiome studies. Leveraging 800 animals with whole genome sequence available and 500
animals with whole exome sequence available, we also propose genome-wide and exome-wide association
studies on measures of microbiome diversity and specific bacterial taxa. This data can then be used to
complement and focus human genetic studies of the microbiome. This will not only further our understanding of
factors that affect microbiome composition, but it will also assist in the development of primate models for
testing disease associations with the microbiome and for testing the ability of therapeutic interventions to alter
the microbiome.

Public health relevance
PROJECT NARRATIVE Previous studies have suggested that the microbiome may be involved numerous diseases and there is an interest in developing therapeutics that are based around manipulating the microbiome. While we know that individuals have different microbiomes and that these are affected by both environmental and host genetic factors, we are largely ignorant of what these specifically are. This project will develop rhesus macaques, a primate animal model with environmental and dietary control that nevertheless is extremely similar physiologically to humans, as a resource for interventional and host genetic studies of the gut, oral, and nasal microbiomes aimed at improving research rigor.